DRIVING PRACTICES AND DRIVING RECORDS RELATED TO EPESE PARTICIPANTS

Investigators from the University of Iowa (Iowa 65+ Rural Health Study) and Yale University (Yale Health and Aging Project) will pretest a telephone questionnaire to gather data on driving and pedestrian practices among surviving participants in each of these two Established Populations for Epidemiologic Studies of the Elderly (EPESE) sites. In some cases, the driving practices will be ascertained from a next-of-kin on those recently deceased members and those unable to participate due to health or other reasons. After pretesting the instrument, investigators will conduct the full scale survey among the eligible participants and link this data to the existing database. The newly created database will be made available to staff at the National Highway Traffic Safety Administration for collaborative analyses of risks for driving accidents and pedestrian accidents. In addition, investigators will work with each state's Division of Motor Vehicles to link the DMV record data to the database at each site.